Urban Revitalization and Long-Term Effects on Diet, Economic, and Health Outcomes

Project abstract This diversity supplement application builds on Urban Revitalization and Long-Term Effects on Diet, Economic, and Health Outcomes (R01CA149105) and seeks to examine the role of resident displacement and moving on various social and psychological outcomes that may affect diet. Through this supplement, we will examine resident relocation as a consequence of neighborhood investments and its potential impacts on social cohesion, neighborhood satisfaction, perceived stress, psychological distress, and diet. We will tap into our existing cohort of households to examine differences between three distinct populations (voluntary movers, displaced movers, and non-movers) and whether moving is associated with changes in the abovementioned outcomes. Through analysis of the survey data as well as semi-structured interviews from the three populations, we will tap into the role that relocation might have with changes in outcomes. The proposed supplement builds on the parent grant by capitalizing on rich longitudinal data, and adds qualitative insights into moving, residential choices and the mechanisms at play. It also offers an ideal opportunity to build the skills and further the career development of a promising doctoral candidate who is committed to the study of structural and policy influences on the health of vulnerable populations.

Public health relevance
Project Narrative This study builds on work following a randomly selected cohort of households in two low-income predominantly African-American neighborhoods, one of which has experienced substantial neighborhood revitalization, including a new full-service supermarket and commercial and residential housing investments. This diversity supplement will examine whether and to what extent neighborhood investments may have resulted in the unintended consequence of displacing residents from the neighborhood and will focus on displacement’s role in social cohesion, psychological distress, and ultimately diet among residents who moved compared to nonmovers. Results will inform understanding of neighborhood investment and its role in resident health and wellbeing and provide an important opportunity for training and development of a promising doctoral student.